Immuno-stromal axes regulate fibroblast heterogeneity in tissue fibrosis and regeneration

Project Summary
Tissue damage due to injury, disease, or congenital defect continues to be a critical clinical obstacle in
human health. Regenerative medicine-based therapies are a promising strategy, yet the critical determinants of
success are the immune response and fibrosis. Typically, in tissue repair, inflammation is closely controlled
before remodeling by activated fibroblasts, whose presence is also tightly regulated. Immunomodulation is a
promising strategy to avoid fibrotic outcomes, yet it is not the immune cells that directly participate in tissue
remodeling and collagen production. Therefore, it is critical to understand how immune cells coordinate stromal
cells to promote tissue repair or fibrosis. In fibrosis, evidence suggests that chronic immune cell infiltration and
proinflammatory cytokines accompany fibroblasts poised to promote fibrosis. Those fibroblasts are characterized
by aberrant mechanotransduction (i.e. sensing “normal”/soft as stiff/scarred) leading to the overproduction of
ECM. We now know that immune cells and fibroblasts exist as phenotypically distinct subpopulations, including
those with a molecular signature tied to fibrosis. Whether inflammatory signals elicit distinct fibroblast
subpopulations with aberrant mechanotransduction in fibrosis is unknown and is a key objective. Understanding
the relationship between inflammation and fibroblast heterogeneity is essential to predict the regenerative
potential of therapies. I hypothesize that fibroblast subpopulations exist during fibrosis with aberrant
mechanotransduction that is regulated by inflammatory signaling. During the mentored K99 phase of this
application, I will identify the immune and fibroblast subpopulations that emerge during tissue regeneration and
fibrosis leveraging non-fibrotic/regenerative microporous annealed particle hydrogels (MAP gels) and fibrotic
nonporous bulk hydrogels (NP gels). I will determine the mechanotransductive differences across those
subpopulations by purifying them with identified markers and measuring ECM production, myofibroblastic
differentiation, integrin activation, and focal adhesion signaling. I will identify signaling pathways necessary for
the phenotypes unique to fibroblast subpopulations. I will validate these findings by confirming the identified
fibroblast subpopulations and signaling pathways in fibrotic clinical implants. I will continue my scientific and
professional development in preparation for the independent phase with consistent guidance from my scientific
advisory committee, diversity advisory committee, and collaborators. During the independent phase, I will
determine mediators unique to regenerative and fibrotic microenvironments using MAP and NP gels. I determine
if IL-1 signaling in fibroblasts is necessary for fibrosis by implanting NP gels in fibroblast-specific IL-1RI knockout
mice. I will also determine whether IL-1 signaling is sufficient to promote fibrosis using MAP gels conjugated with
IL-1?. We pose an innovative hypothesis that seeks to bridge the gap between inflammation and disrupted
mechanotransduction distinctive of fibrotic disorders. This proposal will equip me with scientific and professional
training that will enable me to launch a successful and diverse research program as an independent investigator.

Public health relevance
Project Narrative Tissue damage due to injury, disease, or congenital defect continues to be a critical clinical obstacle in human health and regenerative medicine-based therapies, while a promising strategy, still face two critical obstacles: chronic inflammation and fibrosis. We pose an innovative hypothesis whereby immuno-stromal signaling axes and fibroblast heterogeneity link together inflammation and disrupted mechanotransduction, bridging a critical gap in our understanding of tissue fibrosis and regeneration. Developing a better understanding of immuno- stromal crosstalk will help elucidate disease pathogenesis, new candidates for biomarkers, and targets for therapeutic interventions.